Assessing genome sequence integrity in normal human cells

ABSTRACT
Human somatic cells are exposed to DNA damaging agents on a daily basis from both endogenous
and exogenous sources, resulting in a broad range of DNA lesions, varying from DNA breaks and
abasic sites to bulky adducts and crosslinks, in normal somatic cells perhaps up to 100,000 lesions
per day. Virtually all of that damage is quickly repaired through a complex set of genome maintenance
systems, albeit with errors. Such errors result in DNA mutations, which can vary from base
substitutions and small deletions or insertions to larger genome structural variation, including
chromosomal aberrations. Mutations are true molecular end points, direct indicators of loss of
genome sequence integrity. DNA mutations cause cancer and have also been implicated in age-
related diseases as well as aging itself. To study mutations in humans, the most widely applied
assays are selectable marker assays (e.g., HGPRT), but they can only be applied on cells that can be
cultured and cloned, and of course comprise only a very small part of the genome, precluding a more
global assessment of mutation loads. With the advent of next-generation sequencing, somatic
mutations can be quantitatively assessed, but only in clonal lineages, such as tumors, in which a
substantial fraction of cells harbor the same mutations. In normal tissues, somatic mutations are of
very low abundance and cannot be distinguished from sequencing errors. Detecting mutations in
normal cells and tissues requires either a single cell approach or extremely high accuracy in
distinguishing a true mutation from an artifact in sequenced bulk DNA. We recently developed and
validated next generation sequencing-based assays for detecting most if not all types of mutations
using both bulk DNA and single cell-based approaches. Here we propose to integrate, further
optimize and validate these assays into the first next-generation sequencing-based mutation analysis
system that provides comprehensive insight in genome sequence integrity in normal human cells. For
this proposal, the assay will be tailored to measuring the mutagenic effects of tobacco smoke for
testing the hypothesis that mutations in blood or buccal mucosal cells reflect loss of genome integrity
in human lung in smokers and non-smokers in relation to lung cancer. In Aim 1, we will develop and
validate an integrated and automated assay for measuring the complete landscape of genome
instability in epithelial cells exposed in vitro to tobacco smoke condensate. In Aim 2, we will validate
the integrated assay for genome sequence integrity in human bronchial, buccal and blood cells
exposed in vivo, in relation to tobacco smoke exposure and lung cancer case-control status. The
assay developed in the proposed project would potentially allow, for the first time, the use of global
genome sequence integrity as an endpoint to assess individual risk of lung cancer in relation to
exposure to tobacco smoke, as reflected in non-invasive specimens amenable to epidemiologic
studies.

Public health relevance
PROJECT NARRATIVE Human somatic cells are exposed to DNA damaging agents on a daily basis from both endogenous and exogenous sources, resulting in a broad range of DNA lesions. DNA repair of this damage is a complex process, and errors result in DNA mutations. DNA mutations cause cancer and have also been implicated in age-related diseases as well as aging itself. Here we propose to integrate, further optimize and validate two recently developed DNA mutation assays into the first next-generation sequencing-based, comprehensive assay for testing human genome sequence integrity. The assay will then be tested to measuring the mutagenic effects of tobacco smoke in lung, buccal, and blood cells. The assay developed in the proposed project would potentially allow, for the first time, the testing of global genome sequence integrity to assess individual risk of lung cancer in relation to exposure to tobacco smoke, as reflected in non-invasive specimens amenable to epidemiologic studies.